Mechanisms of WNT Signaling in Bone

DESCRIPTION (provided by applicant): Wnt signaling provides a promising target pathway for developing novel bone anabolic agents. Most studies to date have supported a model in which autocrine or paracrine Wnt signaling in osteoblast-lineage cells directly controls osteoblast biology. This model however, was challenged by a recent study that concluded that LRP5, a co-receptor for Wnt proteins, does not function directly in osteoblasts, but rather through regulating enteric production of serotonin. This study therefore has cast uncertainty about the physiological relevance of direct Wnt signaling in bone. A major cause for the uncertainty is that genetic deletion of β-catenin (an obligatory effector of canonical Wnt signaling) in osteoblasts by 2.3Col1-Cre did not affect osteoblast number or function in postnatal animals. However, previous work in the mouse embryo indicates that Wnt/Lrp5/β-catenin signaling may function at a stage before 2.3Col1-Cre becomes active. Directly testing this notion in postnatal life has not been feasible because of the lack of proper genetic tools. We have now developed a novel Tet-on system that allows for gene manipulation in osteoprogenitors specifically in postnatal mice. Therefore, we propose to delete β-catenin in osteoprogenitors postnatally to test the hypothesis that β-catenin directly regulates bone formation in postnatal life (Aim 1). A second critical barrier to progress in the field is the lack of understanding of the molecular mechanisms that mediate Wnt function in osteoblast-lineage cells. Research has been hindered by the lack of a robust mouse model in which a Wnt protein can be manipulated and assessed for its acute signaling ability in vivo. We have now developed such a model wherein a potent bone anabolic Wnt ligand can be activated in a controlled manner. Therefore, in Aims 2 and 3, we will employ this new mouse model to investigate both biochemically and genetically the signal transduction mechanisms through which Wnt7b induces bone formation in vivo.

Public health relevance
PUBLIC HEALTH RELEVANCE: Novel strategies are required to safely promote bone formation to treat osteoporosis. Wnt signaling has been known to stimulate bone formation and provides a promising target pathway for developing novel bone anabolic agents, but the underlying molecular mechanisms are not well understood. This proposal is designed to understand the mechanism responsible for the potent bone-stimulating function of Wnt proteins. Research results from this study will provide a molecular framework for developing novel bone-enhancing pharmaceutics. Project Narrative Novel strategies are required to safely promote bone formation to treat osteoporosis. Wnt signaling has been known to stimulate bone formation and provides a promising target pathway for developing novel bone anabolic agents, but the underlying molecular mechanisms are not well understood. This proposal is designed to understand the mechanism responsible for the potent bone-stimulating function of Wnt proteins. Research results from this study will provide a molecular framework for developing novel bone-enhancing pharmaceutics. __SpecificAimsTextDelimiter__ Specific Aims Wnt signaling provides a promising target pathway for developing novel bone anabolic agents. Most studies to date have supported a model in which autocrine or paracrine Wnt signaling in osteoblast-lineage cells directly controls osteoblast biology. This model however, was challenged by a recent study that concluded that LRP5, a co-receptor for Wnt proteins, does not function directly in osteoblasts, but rather through regulating enteric production of serotonin. This study therefore has cast uncertainty about the physiological relevance of direct Wnt signaling in bone. A major cause for the uncertainty is that genetic deletion of b-catenin (an obligatory effector of canonical Wnt signaling) in osteoblasts by 2.3Col1-Cre did not affect osteoblast number or function. A logical counterargument is that Wnt/Lrp5/b-catenin signaling may function at a stage before 2.3Col1-Cre becomes active. Although this counterargument is consistent with the embryonic data that deletion of b- catenin with either Dermo1-Cre or Prx1-Cre (both targeting early mesenchyme prior to 2.3Col1-Cre expression) led to no mature osteoblasts, its direct validation in postnatal life has not been possible because those animals die at birth. We have now developed a novel mouse strain (Runx2-rtTA) that, in the presence of a tetO-Cre transgene, directs Cre expression from the Runx2 genomic locus in a doxycycline-dependent manner. Therefore, the first objective of this proposal is to delete b-catenin in Runx2-positive osteoprogenitors postnatally to test the hypothesis that b-catenin directly regulates bone formation in postnatal life (Aim 1). A second critical barrier to progress in the field is the lack of understanding of the molecular mechanisms that mediate Wnt function in osteoblast-lineage cells. Most mechanistic experiments to date have been conducted in vitro with Wnt3a, which is not detected in skeletal cells. We have now developed a novel mouse strain (R26-Wnt7b) that expresses a physiologically relevant ligand Wnt7b in a Cre-dependent manner. We show that mice overexpressing Wnt7b in osteoblasts drastically increased bone mass. When combined with the Runx2-rtTA strain above, this mouse provides a useful model for assessing signaling events upon acute Wnt7b induction in vivo. Therefore, the second objective of the proposal is to investigate the signal transduction mechanisms through which Wnt7b induces bone formation in vivo (Aims 2 and 3). The three specific aims are as follows: 1). Elucidate the role of b-catenin in postnatal bone formation by using a novel doxycycline-inducible mouse model. Postnatal mice will be induced with doxycycline to delete b-catenin in Runx2-positive osteoprogenitors. Impaired bone formation in these animals would establish a role for b-catenin in postnatal bone accrual, and provide critical evidence supporting the importance of direct Wnt/b-catenin signaling in postnatal bone formation. 2). Investigate signaling events in osteoblast-lineage cells following acute Wnt7b induction in vivo. Three potential pathways, mediated by b-catenin, PKCd or mTOR, respectively, will be evaluated in osteoblastic cells upon acute Wnt7b expression. Results from these studies will provide important biochemical basis for the functional studies that follow. 3). Evaluate the contribution of b-catenin-dependent versus -independent mechanisms to the bone anabolic effect of Wnt7b in vivo. We will assess the role of b-catenin by comparing postnatal bones that over-express Wnt7b, with those that over-express Wnt7b but lack b-catenin. In the event that b-catenin does not play a predominant role, the function of PKCd and mTOR will be determined, through genetic or pharmacological approaches, respectively. These experiments will uncover the relative importance of three potential mechanisms in Wnt7b-induced bone formation. Overall, the current study will not only provide critical data towards resolving an important controversy in the field, but also shed light on the molecular mechanisms through which Wnt proteins induce bone formation in vivo. As a result, the field will be advanced significantly.